A new perspective on the role of extracellular vesicles in Alzheimer's disease

ABSTRACT:
Extracellular vesicle (EV) generation and release is investigated as a default waste removal mechanism, a
source of potential biomarkers, for transport of material between cells, and for propagation of pathology
throughout the brain. EVs are highly heterogenous, and each EV subtype contributes to brain physiology and
disease differently. Our laboratory has developed a technique to fractionate EV subtypes from murine and human
brain tissue, identifying a previously unknown subtype of brain EVs of mitochondrial origin, named mitovesicles.
Given the novelty, mitovesicle biology and function(s) have never been investigated. We hypothesize that
mitovesicle secretion into the brain extracellular space eliminates detrimental mitochondrial materials from the
cell, especially when other mitochondrial quality control mechanisms, including mitophagy, are disrupted.
Shuttling from one cell to another, dysfunctional mitovesicles can transfer this mitochondrial content from a single
focal site to the rest of the brain, potentially impairing recipient distal cells. We will test our novel hypotheses
regarding cellular mechanisms involving mitovesicles in the brain, both physiological and pathological, ideas that
are supported by our preliminary findings and are consistent with mitochondria being a point of heightened
vulnerability in Alzheimer disease (AD). We propose in vitro and in vivo studies of all aspects of mitovesicle
lifecycle, including generation, secretion, uptake, and intracellular fate in recipient cells. Furthermore, we will
explore whether mitovesicles isolated from brains of murine models of b-amyloidosis trigger alterations in
otherwise normal tissues that are reminiscent of AD, including changes in mitochondrial dynamics, mitophagy,
reactive oxygen species production, oxidative balance, cell survival, neuroinflammation, and synaptic
transmission, leading to behavioral deficits. Our proposed studies will examine the mechanism initiating changes
in mitovesicles biogenesis and secretion and the downstream effects of these changes. We will study
mitovesicles isolated from the brain of two AD-relevant mouse models of b-amyloidosis, the knock-in APPNL-F/NL-
F and the overexpressing APP23, that preliminary studies have shown to be altered prior to robust b-amyloidosis.
The effect of sex, age, and amyloid b deposition will be considered by analyzing brains of female and male mice
at different ages, comparing a prodromal stage, an age with limited plaque pathology, and an advanced
pathology stage age with extensive b-amyloidosis. In Aim 1 we will investigate mitovesicle biology, including
intracellular biogenesis, transport, release, and uptake of physiological mitovesicles in cultured neurons,
astrocytes, and microglia. In Aim 2 we will investigate the pathogenic changes in mitovesicles in the two b-
amyloidosis mouse models. Findings will be confirmed in mitovesicles isolated from the brain of AD patients, as
compared with non-demented controls. The proposed experiments will determine the balance of beneficial and
pathogenic effects of mitovesicles and have the potential to identify previously unexplored therapeutic directions
to restore the integrity of mitochondria, minimizing the neurodegenerative consequences of AD.

Public health relevance
PROJECT NARRATIVE: The goal of this collaborative study is to investigate the physiological and pathological roles of mitovesicles, a recently discovered subtype of extracellular vesicles of mitochondrial origin in the brain. We will investigate the mechanisms that modulate mitovesicle production and secretion, their intracellular fate once taken up by recipient cells, and the effects of mitovesicles derived from normal brains and from Alzheimer’s disease- relevant mouse models. Our studies aim to identify novel directions for therapeutic strategies that can restore the integrity of mitochondria, minimizing the effects of this pathology in neurodegenerative diseases such as Alzheimer’s disease.